Molecular, Cellular and Circuit Mechanisms for Age-Related Deficits in Memory-Linking

PROJECT SUMMARY
Molecular, cellular and circuit mechanisms for age-related deficits in memory-linking.
Age is the strongest risk factor for Alzheimer’s disease (AD), and therefore, targeting factors that contribute to the onset of
this disorder, such as age-related changes in microglia(1, 2) and Locus Coeruleus (LC) (3, 4), may be key for early
prevention and treatment(5-7). Here, we propose that early age-dependent changes in these two factors contribute to the
onset of memory deficits with aging and AD, including source and relational memory problems(8-12). Our memories
depend not only on the ability to recall individual elements/items, but also on processes that link these elements/items
(source/relational memory) (13, 14). Importantly, source/relational memory is more sensitive to age-related decline than
item memory(8-12). We propose to study middle-aged mice because we found that although contextual memory is still
preserved in these mice (14-18 months), they show robust impairments in their ability to link the memories for two contexts
(15, 16) acquired close in time, a possible early sign of memory deficits relevant to AD. Two memories are linked when the
recall of one triggers the recall of the other(15). In the previous period of this project, we discovered that the temporal
window for the allocation of contextual memories to overlapping ensembles in hippocampal dorsal CA1 (dCA1) is critical
for modulating the temporal window for contextual memory linking (16-18), and that this mechanism is disrupted in middle-
aged mice before any deficits in contextual conditioning itself(16). Importantly, impairments in either LC activation or
dopamine from LC in dCA1, dCA1 inhibition of microglia P2Y12 function, as well as increases in the expression of the
chemokine receptor CCR5 seen with aging, resulted in both deficits in contextual memory ensemble overlap in dCA1, and
in the loss of contextual memory linking (but not in contextual memory itself); In contrast, the depletion/repopulation of
microglia or decreases in CCR5 function, resulted in dramatic extensions of the temporal windows for both dCA1 ensemble
overlap and contextual memory linking (16-18). Here, we propose to use state-of-the-art imaging, chemogenetic and
optogenetic tools to test the novel hypothesis that age-related changes in LC to dCA1 dopaminergic signaling, and
associated changes in microglia function, including CCR5 receptor signaling, result in the premature closure of the
temporal window for memory ensemble overlap, and therefore in age-related deficits in memory linking. To test this
hypothesis, we propose to determine whether age-related changes in LC dopaminergic and microglia function, including
CCR5 signaling, contribute to the loss of age-related dCA1 contextual memory ensemble overlap and contextual memory
linking in middle-aged mice. Importantly, our preliminary evidence showed that dopaminergic activation in dCA1,
decreases in CCR5 function, and microglia depletion/repopulation can all rescue contextual memory linking in middle-
aged mice, thus justifying the experiments proposed here. Beyond addressing molecular, cellular and circuit mechanisms of
age-related changes in memory linking, these studies will also investigate how age-related changes in LC, and microglia
contribute to the onset of cognitive impairments with aging and AD, since decreases in LC activation, and changes in
microglia function have been implicated in both(1, 2).

Public health relevance
PROJECT NARRATIVE The public health relevance of the proposed research is two-fold: First, we propose to uncover the molecular, cellular and circuit mechanisms that underlie age-related deficits in the processes that link memories across time, and deficits in these mechanisms may be some of the earliest signs of cognitive decline and Alzheimer’s disease. Second, the highly mechanistic experiments proposed here could be used to help design treatments for these cognitive problems. Thus, the studies proposed will not only address a novel concept in memory (memory linking(15, 19, 20)), they will also investigate how the Locus Coeruleus (one of the earliest sites of age-related neurodegeneration) and neuroinflammatory mechanisms(21), involving CCL5/CCR5 and microglia(1, 2), contribute to age-related cognitive decline and Alzheimer’s disease.